Mechanisms for building and remodeling microtubule arrays

PROJECT SUMMARY
The Project Summary is contained within the Research Strategy.

Public health relevance
Project Narrative Protein polymers called microtubules are a critical part of the dynamic internal scaffolding of eukaryotic cells. They have the remarkable ability to change their configuration to allow cells to accomplish such different tasks as division, migration, transport of internal material and shape acquisition. Our research seeks to identify and characterize the mechanisms underlying microtubule dynamics and spatial organization, which will contribute to improving human health because defects in these mechanisms are linked to neurodegenerative diseases, cancer, and developmental disorders.